Task A34: In vitro screening for antibacterial activity against biodefense and emerging infectious disease pathogens

This contract provides in vitro testing of potential anti-bacterial and anti-fungal agents, maintenance of bacterial and fungal stocks, and the development of related assays.